BACKYARD BUGS--DISCOVERY BASED SCIENCE EXPLORATIONS

The aim of Backyard Bugs is to prove the feasibility of producing innovative software combining all of these features and characteristics: 1. Promotes science literacy in young children grades k-4; 2. Is correlated to the National Science Education Standards; 3. Features virtual "live" insects; 4. Is discovery-based; 5. Follows software usability guidelines; and 6. Is founded on theory-based instructional strategies. Science education in the United States must once again become a top priority if this nation is to continue to lead the way in this world of rapid growth of scientific knowledge and technological development. The proposed software will fill a gap in currently available science education offerings. Established educational multimedia production techniques will be used in order to concentrate on creating a powerful, dynamic learning environment. The final software will include appropriate virtual investigative science tools, tables, graphs, explorations and video clips, all in a virtual outdoor environment. Criterion-referenced pre- and posttests will be used to assess and evaluate the effectiveness of the software design as conceptualized and the data analysis will yield a measure of feasibility. The platform-independent, template-based software design will support commercialization by providing the means for the development of future science education software products. PROPOSED COMMERCIAL APPLICATION: Kinder Magic Software has successfully created and marketed children's educational software. Science software is the fastest growing category of children's software titles. Currently, science software offerings for children numbers over 500 titles, representing 15% of children's software titles in the United States. The proposed software will be appropriate for use in public and private schools, after school programs, home schooling, and consumer use. The audience for the proposed software includes the 20,000,000 US school children enrolled in grades K-4. Some comparable single title are generating yearly sales of about $1 million.